Optimizing Employee Well-being and Retention during Electronic Health Record Modernization

Background: VA’s ongoing electronic health record modernization (EHRM) represents one of the largest and
complex organizational initiatives VA has undertaken. VA leadership recognizes the ability to consistently
provide high quality care depends on a fully staffed and highly effective workforce. VA’s current EHRM
initiative, if poorly implemented, is a major threat to this operational need. Early work indicates that EHRM at
the first site to undergo transition (i.e., go-live) was profoundly disruptive to clinicians, adversely impacting
perceptions of the EHR, employee morale and the ability to deliver clinical care. VA operational leaders are in
urgent need of information to alter the course of EHRM to ensure the well-being of a fully staffed and high
functioning health workforce.
Significance: The proposed study will generate timely data-driven insights to enable operational and facility
leaders to enact fast-paced decisions and strategies designed to mitigate undesirable workforce outcomes
resulting from EHRM including turnover, absenteeism, burnout. Findings will also inform the strategic delivery
of workplace intervention by identifying VA clinician subgroups at highest risk of adverse workforce outcomes.
EHRM is expected to continue for several years, and study findings will provide actionable insights to support
change readiness and improve EHRM processes at facilities awaiting go-live.
Innovation and Impact: The key innovation of the study is the generation of new scientific knowledge that
comprehensively identifies how EHRM affects four workforce outcomes: turnover, absenteeism, burnout, and
engagement. New insights gained from this study will provide timely insights to meaningfully improve the
course of EHRM in VA and guide other non-VA health systems planning their own EHRM.
Specific Aims: Project specific aims include: 1) examine the association between EHRM implementation and
workforce outcomes using econometric methods, 2) explore key EHRM related themes associated with
workforce outcomes using longitudinal qualitative methods and 3) design and administer a survey to identify
key EHRM factors associated with workforce outcomes.
Methodology: This multi-methods study will examine the effects of EHRM across VA nationally. Data sources
will include employee information from the VA Corporate Data Warehouse, Personnel and Accounting
Integrated Data files, HR SMART database, the VA All Employee Survey, and semi-structured interviews. In
Aim 1, a quasi-experimental study design will be applied to quantitatively identify overall and subgroup effects
of EHRM by leveraging pseudo-random variation in the staggered implementation of EHRM. In Aim 2, we will
collect and analyze qualitative data from key informant interviews to explore EHRM-related elements
associated with workforce outcomes. Data will be collected from remaining and separated clinicians at sites
expected to go-live in the proceeding months. Aim 3 will apply multivariable regression techniques to examine
relationships between perceptions of EHRM elements and workforce outcomes using new survey data
collected in this study.
Implementation/Next Steps: Study findings will be used to inform the design and modification of tools to
effectively implement the new EHR and/or promote positive workforce outcomes. This includes a new strategic
playbook of bottom-up approaches to improve EHRM, to be developed in collaboration with a panel of VA
stakeholders. Product development will capitalize on strong working relationships with operational partners
developed in prior research including leaders of the Office of the Functional Champion.

Public health relevance
Our primary goal is to optimize employee well-being and support retention of VA’s workforce during electronic health record modernization (EHRM), one of the largest and most complex organizational initiatives VA has undertaken. The process of EHRM substantially disrupts multiple sociotechnical systems and challenges clinicians who rely on the EHR to deliver high quality care. The success of VA in delivering exceptional health care to Veterans critically depends on maintaining a fully staffed and high functioning workforce, however, VA’s EHRM initiative is a major threat to this operational need. Early work by the study team indicates that EHRM at the first implementation site was profoundly disruptive to frontline clinicians, adversely impacting morale and uncovering narratives of greater absenteeism and turnover. This multi-methods study will generate timely data- driven insights to identify and mitigate undesirable workforce outcomes (e.g., turnover, burnout) resulting from EHRM to ensure VA’s workforce is ready to consistently deliver world class services to Veterans.